Core A: Administrative Core

The Administrative Core provides the infrastructure and centralized support that will enable all four research projects to be productive and collaborative. This will be achieved by the following aims: Aim 1: Administration and fiscal management. The administrative core will provide oversight of administrative and budget matters including human resources, fiscal management, conflict resolution, institutional regulatory compliance (i.e. IRBs), and all communication with NIH. Aim 2: Communication management. The administrative core will schedule and facilitate monthly project leader and P01 staff meetings for dissemination of scientific findings, organize the annual scientific advisory panel visit and the executive committee meetings, and foster a collaborative scientific environment (advertising seminars, work-in-progress meetings, attendance at meetings to disseminate research findings within the scientific community, etc.). Aim 3: Scientific oversight. The administrative core will ensure scientific integrity such as data sharing plans and data management and assurances. The administrative core will also provide support for laboratory equipment. Aim 4: Statistical data analysis support. The Core will provide statistical support and oversight that include recommendations for experimental design to achieve desired statistical power, power calculations to determine group sizes, recommendations for data transformations to achieve forms appropriate for statistical analysis and advice regarding appropriate statistical tests to employ during the data analysis phase.

Public health relevance
Centralization of administrative responsibilities within the Administrative Core will promote synergy and communication between the individual Projects to allow for integrated data analysis and interpretation. The Administrative Core is expected to have a positive impact on the Program as it will strive to provide a solid platform for management, statistical and administrative support of the individual projects.